Interdisciplinary and Inclusive Predoctoral Training in Molecular, Cellular, and Biochemical Sciences

Promoting wellness and strategies for building resilience is important for retaining talented
scientists, especially women and underrepresented minority scientists, in the workforce, and
facilitating their long-term success. The activities proposed here would fill an important gap in our
offerings, and address an increased need for access to these resources brought about by the
pandemic. We propose to build upon and sustain the NIH's "Becoming a Resilient Scientist"
series at Brown via three primary activities: 1. Development and delivery of an expanded resiliency
curriculum; 2. Engagement of Resiliency Ambassadors who will serve as peer facilitators; and 3.
Recruiting additional faculty to participate and train to be future facilitators of the curriculum. The
three faculty that will lead this initiative are trained facilitators who piloted the NIH content and
facilitated discussions in Fall 2021. Based on feedback collected from the initial cohort of 20
trainees, we propose to develop this content into a course with additional interactive content,
including expert guest speakers and experiential learning activities. We will recruit participants from
the parent T32 program, as well as our other NIGMS-funded T32/R25 programs, doctoral programs
in the Division of Biology and Medicine, and postdoctoral trainees from life science disciplines
across the university. Indeed, we currently have a waitlist of trainees eager to obtain resiliency
training, and who will benefit from the proposed course. Peer facilitators who have been involved
in resiliency content previously will further engage course participants, serve as a resource, and
participate in dissemination of the course experience and outcomes. Additional faculty facilitators
will be trained to help sustain the course in future years and advocate for resiliency supports.
Altogether, we aim to build a community of resiliency at Brown, which will, in turn, support the
continued success of our trainees as they build careers in the biomedical sciences.

Public health relevance
Project Narrative The development of resilience and the confidence to handle stress and conflict are important for trainees as they prepare for research careers. This supplement will build out a curriculum of resilience training, using evidence-based approaches established by the National Institutes of Health. It will also grow a community of resiliency, by engaging experienced peer facilitators and training faculty to sustain the curriculum in future years.